Endogenous zinc protoporphyrin in intracerebral hemorrhage

Project Summary
Intracerebral hemorrhage (ICH) is a leading cause of mortality. Despite extensive efforts, current therapeutic
interventions targeting recognized causes of ICH-induced brain damage have been ineffective. Our recent
study revealed an intriguing finding: endogenously formed zinc protoporphyrin (ZnPP) significantly contributes
to ICH brain damage. Our preliminary results show that ICH-generated ZnPP accumulated in brain tissue
surrounding the hematoma, which was dependent on ferrochelatase (FECH) catalysis. Notably, inhibiting
FECH markedly reduced ZnPP generation, decreased brain damage, and improved long-term outcomes.
However, little is known about the factors that are required for ZnPP formation, nor the mechanisms by which
ZnPP exerts its neurotoxicity in ICH. Building upon our published and preliminary findings, our overarching
hypothesis is that ICH causes a hypoxic rim around hemorrhagic area, triggering ROS generation, free Zn2+
release and iron oxidation, and promoting FECH-mediated formation of ZnPP; subsequently, ZnPP contributes
to brain damage via HO-1 inhibition, HIF-1α upregulation, Zn toxicity enhancement and ROS generation. In
Aim 1, we will determine conditions for ZnPP generation and how ZnPP contributes to brain damage following
ICH. We will test the hypothesis that ICH-induced local tissue hypoxia increases Zn2+ release and Fe3+/Fe2+
ratio, promoting the Zn2+ insertion by FECH to generate ZnPP, ultimately leading to brain damage through HO-
1 inhibition and further increased Zn2+ release ROS generation. In Aim 2, we will determine why ZnPP is toxic
in hypoxia and whether oxygen treatment could mitigate ZnPP-induced brain damage following ICH. We will
investigate the hypothesis that ICH-induced tissue hypoxia enhances ZnPP formation by promoting oxidative
stress and zinc release and exacerbates brain injury by upregulation of HIF-1α. We will also evaluate the effect
of normobaric oxygen on reversing brain damage and improving outcomes. In Aim 3, we will determine
whether off-target FECH inhibition by protein kinase inhibitors reduces peri-hematoma ZnPP level and
alleviates brain damage in ICH. We will investigate FECH requirement for ZnPP generation and associated
brain damage. Additionally, we will evaluate the efficacy of FDA approved off-target FECH inhibition drugs in
mitigating ICH-induced brain damage and improving neurological outcomes. The findings form this project will
clearly elucidate the intricate relationship between ZnPP, ROS, Zn2+ and Fe3+/Fe2+, providing an
unprecedented mechanistic picture underlying ICH brain injury. Furthermore, the results will reveal the
relationship between brain pO2 and ZnPP toxicity, demonstrating that the differential toxic vs. neuroprotective
properties of ZnPP is dependent on hypoxia, resolving the current controversy on the role of ZnPP in various
biological systems. Most importantly, our approach to pharmacologically inhibit ZnPP-induced exacerbation of
brain damage may pave the way for the development of new therapies for ICH, either alone or in combination
with other treatments.

Public health relevance
PROJECT NARRATIVE As a leading cause of death and disability, hemorrhagic stroke due to intracerebral hemorrhage (ICH) has a great effect on public health. However, the currently recognized mechanisms of ICH-induced brain damage have not proven very amenable to therapeutic intervention; so, there is the urgent unmet needs to discover other mechanisms and develop more efficacious interventional strategies. This project will investigate a novel molecular mechanism of ICH-induced brain damage, and study whether the currently FDA-approved cancer drugs could be used as a promising intervention for ICH.